Virus-driven human gene misregulation in disease

ABSTRACT
Thousands of genetic variants have been established for hundreds of human diseases. Yet, the vast
majority of these diseases remain idiopathic. Interplay between genetics and the environment likely plays a role
in many diseases. In particular, hundreds of associations between viral exposure and disease risk have been
established. But with rare exceptions, the mechanisms underlying increased disease risk are unknown. We have
recently discovered that the Epstein-Barr virus EBNA2 transcriptional co-factor binds up to half of the risk loci
associated with seven autoimmune diseases (142 loci in total), with many examples of allele-dependent EBNA2
binding to autoimmune risk variants. We hypothesize that risk allele-dependent binding of viral TFs explains
why other viruses cause or influence specific diseases. However, the data required to discover these
mechanisms are currently incomplete. Herpesviruses and human papilloma virus play established roles in
several human diseases, and their genomes encode many TFs. We will generate the functional genomics
datasets needed to discover the roles of these viral TFs (vTFs) in human disease processes. We anticipate
discovering multiple causal human disease variants whose mechanisms act in a viral TF and allele-
dependent manner, leading to understanding of disease mechanisms and new therapeutic opportunities. Our
approach is a generalizable blueprint for global characterization of pathogenic effects on host gene regulation.
Aim 1. Create global maps of viral TF-driven human gene regulation. For eight viruses, we will
transfect a viral TF into physiologically and pathologically relevant human primary cells and cell lines. We will
measure the effect of vTFs on human gene expression by performing RNA-seq in cells with and without vTF
transfection. We will monitor the binding of vTFs to the human genome using chromatin immunoprecipitation
and calculate the enrichment of each vTF at established risk loci for all human diseases using our RELI algorithm.
Aim 2. Uncover the mechanisms and downstream functional impact of viral TF-human genome
interactions. We will characterize the mechanisms by which vTFs alter the human regulatory landscape. We
will measure the effect of vTFs on human chromatin accessibility (ATAC-seq) and DNA looping (HiChIP-seq).
We will use these datasets to construct computational models evaluating disease-relevant mechanisms. We will
examine downstream effects of vTF activity on human cell phenotypes by monitoring cell proliferation, cytokine
release, and growth factor release subsequent to vTF transfection.
Aim 3. Test the allele-dependency of viral TF-provoked human disease mechanisms. We will
identify vTF interactions involving human disease risk allele-dependent mechanisms. We will functionally
screen for vTF- and disease risk allele-dependent effects on gene regulatory activity using Massively Parallel
Reporter Assays. We will interrogate virus-host genomic datasets for allelic behavior using our MARIO
computational pipeline. We will validate risk allele-dependent vTF mechanisms using CRISPR-based genome
editing.

Public health relevance
NARRATIVE The proposed research is relevant to human health because it will generate data revealing molecular mechanisms used by viruses that impact human disease. The project is relevant to the mission of NHGRI because it employs cutting-edge technologies to provide genome-scale insights into human disease processes.